Core A: Administrative Core

ABSTRACT (Core A)
The Administrative Core (Core A) will provide support and effort coordination for each of the
projects in this P01, as well as the two scientific cores. The aims of the Administrative Core are
to ensure that the resources within the P01 are distributed equitably to the investigators and that
all rules and regulations of the National Cancer Institute and the National Institutes of Health are
followed. The Administrative Core will coordinate meetings of the investigators and their
laboratories and facilitate communication between our investigators with the External Advisory
Board. The finances of the P01 will be organized by Ms. Jenine Iannaccone, Grants Administrator
in the Department of Radiation Oncology, who will meet monthly with the P01 Principle
Investigator and quarterly with each Project and Core Leader. Ms. Andrea Rycroft, Administrative
Coordinator, will coordinate travel arrangements for the members of the P01, as well as the
advisors who will visit the University of Pennsylvania. She will also provide administrative support
for each of the P01 investigators for efforts related to the Program. It is anticipated that through
the combined efforts of the Core Director Ms. Rycroft and Ms. Iannaccone, the research
operations and communications of the P01 will run with optimum efficiency